Sidney Kimmel Cancer Center LAPS Institutional Collaboration

ABSTRACT
The overarching goal of the Sidney Kimmel Comprehensive Cancer Center (SKCCC) is to leverage
research expertise to reduce the overall incidence, burden, and mortality from cancer in Greater
Philadelphia and beyond. SKCCC goals are realized through unique strengths in addressing cancer
problems through collaboration across basic, clinical, and population research disciplines. SKCCC is a
NCI-designated comprehensive cancer center nucleated at the Jefferson Health-Center City campus and
enriched by fully integrated regional research sites. Building on these strengths, SKCCC focuses on
nurturing transdisciplinary research, expanding innovative research capabilities, extending outreach and
clinical research into the community, and enhancing the pace of bench-to-bedside discovery. The
Jefferson Health system has expanded and now includes a system of 18 Hospitals treating more than
10,000 new cancer cases annually. The SKCCC catchment area includes Philadelphia, Montgomery,
Delaware, and Bucks counties in Pennsylvania, and Camden and Gloucester Counties in New Jersey.
Philadelphia's highly diverse population, with numerous socioeconomic, racial, and health challenges
characteristic of major northeastern cities, shapes SKCCC research priorities and outreach. At any given
time, hundreds of research studies are underway at the cancer center, ranging from basic laboratory
research to clinical assessments of new treatments to meet the needs of this diverse population. Many of
these studies are collaborative, involving other cancer centers or partners in industry and the community.
The overall objective and goal of this proposal is to enable SKCCC to continue to participate as a Lead
Academic Participating Site (LAPS) in the NCI National Clinical Trial Network (NCTN) Clinical Research
Program. This goal will be achieved through providing scientific leadership for development and execution
of NCTN trials complemented by an integrated and collaborative research program. The SKCCC has an
established and well-supported infrastructure to nurture discoveries that advance our fundamental
knowledge of cancer biology and implement them into the community. As an NCI-designated
Comprehensive Cancer Center, SKCCC addresses the cancer needs of a diverse population through
integration of laboratory and population-based clinical research, engagement of the community in relevant
research, community outreach, and education regarding clinical trials. We propose the following specific
aims in this LAPS application: Specific Aim 1: Deliver and enhance access to the most advanced cancer
care through participation and dissemination of NCTN initiatives including trials for rare tumors across the
SKCCC. Specific Aim 2: Promote and support the scientific leadership within the NCTN. Specific Aim
3: To foster junior faculty investigators’ career development through NCTN participation in both NCTN/NCI
committee engagement and as key contributors to conceptual protocol designs.

Public health relevance
Narrative The Lead Academic Participating Site (LAPS) funding opportunity is intended to provide infrastructure support for the conduct of national clinical trials through the National Clinical Trials Network (NCTN). The overall objective and goal of this proposal is to allow for the continued support and participation of the SKCCC as a Lead Academic Participating Site (LAPS) in the NCI National Clinical Trial Network (NCTN) Clinical Research Program. This goal will be achieved through providing scientific leadership for development and execution of NCTN trials complemented by an integrated and collaborative research program.